Host Defense Training in Allergy and Infectious Diseases

PROGRAM SUMMARY/ABSTRACT
The Division of Allergy and Infectious Diseases at the University of Washington has trained 158
physician-scientists through continuous funding provided by this training grant since its inception in 1976. More
than 75% of trainees have taken academic or research positions and this track record has been maintained.
Many former trainees have achieved leadership positions, with 5 of the former trainees becoming Dean or
Associate Dean of Medical Schools, 3 Chair of Medicine, and 13 Chief of Division. Thirty-six have become full
Professor, 11 are leaders in pharmaceutical companies, and 3 have served as Directors of Divisions or major
Programs at the CDC. Trainees that have finished in the past 15 years have had remarkable early success in
research careers, including >50% achieving research funding, 26% with K awards, and 98% publishing one or
more papers related to their supported research. The continuing objective of the program is to provide post-
doctoral training for physician-scientists committed to a research career in infectious diseases. Eight
postdoctoral training stipends per year are requested, the same number as in the previous funding period.
There are currently 49 participating mentors with $163 million annual direct research funding and outstanding
mentorship records. Each trainee selects a mentor (or more than one) for detailed research training in one of
six research tracks including Virology, TB, Immunology, Emerging Infectious Diseases, Bacterial Pathogenesis
and the Microbiome, and Epidemiology/Clinical Trials. All trainees are assigned a mentoring committee that
meets at least annually and evaluates the trainee. All trainees complete a core curriculum consisting of
required didactic, research and clinical activities. Many trainees elect to take formal course work at the
University of Washington and an average of 2-3 a year seek an MPH or MS degree. The program generally
requires three years of training, one clinical year supported by the hospitals and two research years supported
by this training grant.

Public health relevance
NARRATIVE Infectious diseases continue to extract a considerable individual, social and financial toll on humans due to factors such as the ongoing global epidemic of HIV/AIDS, increasing antimicrobial resistance rendering some pathogens untreatable, and emerging infectious diseases as reflected by the pandemic of coronavirus infection caused by SARS-CoV-2; in fact, infectious diseases represent the leading cause of morbidity and mortality worldwide. The training of new scientist-physicians who can elucidate the epidemiology, microbial pathogenesis, and host response to infectious agents is critical for the formulation of new and improved strategies to diagnose, treat and prevent infectious diseases that impact humans.